GHES - OBSSR - Wild

PROGRAM SUMMARY
The objective of our LAUNCH program is to continue our global health research training program
called the Global Health Equity Scholars (GHES) designed to create a new community of
researchers, educators, and professionals who are prepared to address new and emerging global
health challenges. We will build on the last nine years of this training program to create a cadre of
new researchers who will dedicate their research careers to address the health problems that arise
out of the inequity of human conditions prevalent in informal human settlements (slums). Rather
than addressing one disease at a time, we propose to provide a comprehensive, multidisciplinary,
and integrated approach to deal with urban and rural informal human settlement health issues,
developed over many years by the participating faculty members of this program. This program
will comprise four US partner institutions (Consortium) - Yale University, Stanford University,
University of Arizona, and University of California at Berkeley, each led by a leader in global health
research with more than 10 years of collaboration among themselves. Together, core faculty
mentors from these institutions conduct research at 25 institutions in 21 countries, representing
regions of Africa, Central and South America, the Caribbean, Asia, the Pacific, and Eastern
Europe. The GHES program will address a wide range of health research topics including
HIV/AIDs, emerging and high-consequence infectious diseases, non-communicable diseases
(NCDs), women's health, environmental health, mental health, interpersonal violence, substance
abuse, injuries, and the interaction of all of these health issues within the framework of slum health.
Training will target US postdoctoral fellows and pre-doctoral students and low and middle-income
country (LMIC) postdoctoral fellows. We plan to recruit 9-10 trainees/year with 60% of them as US
postdoctoral fellows. The trainees will spend 10-12-months at an LMIC site under the supervision
of the Consortium and their collaborating LMIC mentors. Workshops on global health research
methods, skill development and career development will be conducted both in-person and online.
LMIC trainees will spend 2-3 months at US institutionsto undergo training in methods not provided
at their institutions. All of the trainees will be provided with research and career mentorship
throughout their training and tracked for career development after completion of their GHES-
supported research work. Thus, under this program, we expect the trainees to be exposed to one
important theme in global health research - health equity - through research that deals with health
concerns of vulnerable populations residing in informal human settlements and provide them with
an opportunity to become experts in this new global health discipline. The overall impact of this
training program is, therefore, to create a new cadre of global health researchers and leaders who
address the emerging health issues arising out of ever-expanding informal human settlements of
LMICs.

Public health relevance
PROGRAM NARRATIVE This training program is specifically designed to train a new cadre of researchers and leaders to address major but as yet under-studied public health problems engendered by conditions prevalent in urban and rural informal human settlements (slums) of low and middle-income countries (LMIC). This training is relevant also to developed countries as informal settlements in the form of homeless encampments expand. Selected candidates will undergo field training on site in LMICs to develop new global health research skills framed within our project research theme of health equity.